Administrative Core

The Administrative core will be responsible for the overall management of this HIVRAD. This Core will be responsible for interacting with DAIDS Program Officer and Staff as required by the funding mechanism as a multi-project cooperative agreement between our team and the NIH. The Core will coordinate all aspects of routine program management on administrative, financial, and regulator issues. The Administrative Core will also organize and interact with external advisors, and host annual external reviews. This Core has the following four Specific Aims: 1- To coordinate the interactions a) among scientists from different institutions included in the current program and b) between our team and Scientific Advisory Board members and NIH personnel regarding efficient implementation of the proposed plans and projects. 2- To oversee budgetary matters, including review and approval of subcontractual agreements, monitoring of monthly expenses and preparation of various reports. 3- To develop an Intellectual Property plan and provide logistical support for intellectual property filings and negotiations 4- To coordinate publications and presentations of results arising from these studies.

Public health relevance
This program involves scientists working at 4 different locations throughout the US and 2 sites in South Africa. For this program to operate efficiently and productively, a centralized Administrative oversight is essential. This will be provided by Dr. Pinter and his assistants, who will be responsible for coordinating communication between the participating scientists, NIH Program Officials, and internal and external Scientific Advisory Committees, and will facilitate other scientific, legal and logistical issues that may arise